Development of a shelf-stable universal mucosal HA-vaccine for the prevention of influenza

PROJECT SUMMARY
TFF Pharmaceuticals (TFFP) is developing a shelf-stable thin-film freeze (TFF) dry powder universal flu
vaccine. Commercialization of this product would provide the first vaccine that is at least 75% effective against
symptomatic influenza virus infection, with the added benefit of easy delivery and storage at room temperature
to facilitate broad, cost-effective distribution. With NIAID’s Collaborative Influenza Vaccine Innovation Center
funding, the University of Georgia (UGA) has developed a recombinant vaccine against all influenza virus
hemagglutinin (HA) proteins and demonstrated its efficacy in mice and ferret models. If shown to be effective in
humans, it could provide broad protection against both known and previously unrecognized strains of influenza
virus, establishing a new standard of protection against seasonal viruses while heading off the emergence of
novel strains in the future. A traditional liquid version of this vaccine would provide enormous benefits relative to
the current seasonal vaccines, but they require cold-chain handling that increases costs and presents substantial
barriers to establishing a stockpile or distributing the vaccine in underdeveloped areas. To address these
challenges, UGA is collaborating with TFFP to develop a dry powder formulation of the universal vaccine. Using
a thin-film freezing (TFF) technique, TFFP can formulate and manufacture dry powder vaccines that maintain
immunogenicity while withstanding unintentional freezing. The vaccine powder can be stored and shipped free
of cold-chain handling with extended stability for stockpiling. Our preliminary studies demonstrate that a
reconstituted TFF-formulated version of UGA’s HA vaccine elicited the same level of immunogenicity and
achieved the same protective efficacy as the original liquid vaccine in BALB/c mice. A follow up study in ferrets
confirmed the efficacy of the TFF-HA vaccine in reducing viral titers in nasal swabs and preventing weight loss.
In this Direct to Phase II SBIR, TFFP and UGA propose to evaluate different adjuvants for intranasal and
pulmonary inhalation delivery and confirm the stability, immunogenicity, and efficacy of the TFF-formulated HA
vaccine in ferrets, the gold standard for influenza virus vaccine testing (Aim 1). Aim 2 will scale-up manufacturing
of the inhaled TFF-HA dry powder vaccine for subsequent toxicology studies in rats (Aim 3); we will also develop
GMP formulation and manufacturing for clinical trials. This project is expected to provide all required IND-
enabling studies to prepare an IND package and ultimately advance to human testing. A dry powder vaccine
would eliminate challenges in shipping and storage, reducing the cost and complexity of vaccine stockpiles and
vaccination campaigns. A shelf-stable universal influenza virus vaccine would also revolutionize the public health
approach to influenza, providing a low-cost, broadly disseminable vaccine that is at least 75% effective against
sympotmatic influenza virus infections regardless of which viral strain emerges each year.

Public health relevance
PROJECT NARRATIVE Each year, seasonal influenza viruses are responsible for hundreds of thousands of deaths and hundreds of billions of dollars in costs worldwide. This study is designed to advance the development of a shelf-stable dry powder formulation of a novel universal influenza virus vaccine that is more than 75% effective against symptomatic influenza virus infection and protects against groups I and II influenza A viruses, the form of virus that has historically given rise to all known influenza pandemics and that contributes to seasonal flu each year. If successful, this work could provide a first-in-class stable, easy-to-transport and easy-to-stockpile vaccine that would overcome the vaccine failures that result from mishandling, mismatches between predicted and actual seasonal flu strains, and evolutionary changes in influenza viruses across the season.